Shared Resource Core 1: Molecular Data Science and Advanced Dosimetry

PROJECT SUMMARY
The convergence of radiation oncology, cancer genomics, data science, computational modeling, and artificial
intelligence presents spectacular opportunities and challenges. In the Harvard/UCSF ROBIN, we propose to
capitalize on these opportunities to improve our understanding of radiation response and resistance. The
clinical vehicles for our ROBIN Center are diffuse midline gliomas (DMGs) and neuroblastoma, the two most
clinically significant pediatric tumors of neural ectodermal origin. We hypothesize that intratumoral
heterogeneity drives radiation response and resistance, and that the mechanisms thereof can be identified by
deciphering tumor cell-intrinsic and -extrinsic components of the tumor microenvironment before, during, and
after radiotherapy. The Molecular Data Science and Advanced Dosimetry Core (Data Science Core) is an
essential component of the Harvard/UCSF ROBIN Center. It will serve as the hub for data storage and
management, analysis, and integration of all molecular datatypes generated by the Center, advanced
dosimetry modeling, and predictive computational modeling platforms. Specifically, the Core will work to (i)
retrieve, curate, and manage molecular data related to the Harvard/UCSF ROBIN Center and provide the
infrastructure necessary to efficiently provide access to all data required for achieving the ROBIN goals; (ii)
analyze and integrate all molecular data types generated in Projects 1 and 2; (iii) generate advanced
dosimetry data, including accurate distributions of dose for radionuclide therapy and dose received by tumor
cells, that are required to investigate the biological hypotheses proposed in Projects 1 and 2; (iv) conduct
mechanistic modeling of radiation effects and evolution of resistance to radiotherapy that directly supports the
aims of Projects 1 and 2 and can inform data collection and address the hypotheses of the ROBIN Center;
and (v) share findings and novel methods with the ROBIN Network and the scientific community at large.
Toward these ends, the Core will coordinate its activities closely with Projects 1 and 2 and the other cores, in
particular with the AI Core, focusing on imaging, radiomics, and natural language processing, and the
Molecular Characterization Trial. The Core will also work closely with the Cross-Training Core and the
Administrative Core to reach other members of the ROBIN Network and the larger scientific community. The
Core will be directed by two investigators, Drs. Michor and Seo, who have expansive and complementary
expertise and have assembled a team of experienced investigators to contribute to the goals of the Core. We
anticipate that the results of the Data Science Core will be broadly utilized by all components of the ROBIN
Center and the larger ROBIN Network as well as the broader scientific community, and will significantly
contribute to understanding data science and dosimetry/cancer evolution aspects across a broad suite of
cancers and treatments.